Rutgers Youth Enjoy Science (RUYES) program

Project Summary. New Jersey has significant cancer disparities across certain population groups, which also
remain underrepresented in the cancer research and healthcare workforce. Increasing workforce diversity is
one of the key strategies for reducing cancer inequities. In alignment with the National Cancer Institute’s (NCI)
mission to train and educate a diverse workforce to reduce cancer health disparities, the goal of the Rutgers
Youth Enjoy Science (RUYES) program is to increase the diversity of the biomedical, specifically cancer
research workforce. The ongoing RUYES program at the Rutgers Cancer Institute is funded by the NCI grant
R25 CA247785 awarded in September 2020. In the current funding period, we have successfully engaged 58
participants, including high school science teachers, high school and undergraduate students, in mentored
cancer research, professional development, and community outreach since the summer of 2021. The
outreach initiatives undertaken by RUYES participants have positively impacted thousands of individuals within
their families and communities, ultimately bolstering the importance of science education and careers. This
renewal application introduces new components and learning opportunities to further enhance our highly
successful RUYES program. These additions are informed by valuable lessons learned and stakeholder
feedback. In the next funding period, we propose a holistic program that focuses on student success, includes
new research experiences in Population Sciences and Cancer Health Equity, a virtual Community Scientist
Training Program, and partnerships with Minority-Serving Institutions (MSI) and Historically Black Colleges and
Universities (HBCUs). We expand our approach to 1) Provide robust support to middle school and high school
science teachers and undergraduate faculty in MSI and HBCUs, offering mentored cancer research experience
and comprehensive help with curriculum development; 2) Actively engage high school and undergraduate
students from diverse backgrounds in mentored hands-on cancer research, as well as provide extensive co-
curricular and professional career development activities; 3) Create dynamic and impactful cancer-related
outreach activities that actively connect program participants with schools and families in their communities. In
our renewal proposal, we will leverage our experience and track record of highly successful pathway programs
with excellent outcomes, a multi-disciplinary research environment, and robust educational and outreach
resources of our Cancer Institute, the state’s only NCI-designated Comprehensive Cancer Center. Our
strategically forged synergistic partnerships with similar initiatives across and beyond Rutgers will ensure that
RUYES continues to expand on its achievements in preparing the next generation of a diverse cancer research
and healthcare workforce.

Public health relevance
Project Narrative The Rutgers Youth Enjoy Science project is relevant to public health because it will develop a more diverse biomedical, cancer research and healthcare workforce to reduce cancer health disparities in New Jersey and nationally. This project at the Rutgers Cancer Institute of New Jersey will train, motivate and support students from underrepresented groups to pursue biomedical, cancer research careers. High school and undergraduate students will engage in mentored hands-on research experience, co-curricular and professional career development activities and science teachers and undergraduate faculty will be provided with mentored research experience and curriculum development support. Innovative outreach activities will connect program participants with schools and families in their communities to enhance awareness and appreciation of science education and research careers.